PHASE 1 AND PHASE 2 CLINICAL TRIALS FOR NEXT-GENERATION CORONAVIRUS VACCINES

THE OBJECTIVE OF THIS TASK ORDER SUPPORTS NIAID'S GOAL TO CONDUCT A SERIES OF STANDARDIZED PHASE 1 AND PHASE 2 TRIALS ON NEXT-GENERATION VACCINES TO GENERATE DATA TO INFORM DECISIONS ON WHICH CANDIDATE TO ADVANCE.